BIOLOGICS SUBJECT MATTER EXPERT (SME) CONSULTING SERVICES

Performance Area 2: PK/PD and ADME studies SME(s)
SME consultants will be required to evaluate PK/PD and ADME study protocols and data, assist with study design, and advise NIH staff on the establishment of milestones related to PK/PD and ADME. The role of the nonclinical consultants may include, but is not limited to, the following responsibilities and tasks:

a) Serve as the PK/PD and ADME expert in order to identify potential drug discovery and development challenges such as lead identification and lead development and suggest strategies to address these challenges

b) Collaborate on design of investigative PK/PD and ADME studies, PK/PD and ADME strategy, experimental design, data analysis and interpretation for discovery and translational projects in support of NIH biologics development projects

c) In partnership with other consultants, contractors, and the NIH staff, advise, strategically plan, and manage PK/PD and/ ADME programs to facilitate bioassay development, lead optimization, formulation activities, IND enabling, and clinical studies

d) Support in vivo efficacy study design in appropriate animal models of neurological disease

Performance Area 3: Toxicology SME(s)
Toxicology SME consultants will be expected to provide senior-level expertise and contribute feedback and guidance on projects to the NIH and to LDT members through conference calls and by email. The role of the consultants may include but are not limited to the following responsibilities and tasks:

a) Help establish toxicology endpoints and milestones for a project, recommend bioassays to be incorporated into a testing funnel or development plan, design toxicology and pharmacology studies, and interpret data delivered by CROs.

b) In partnership with other consultants, contractors, and the NIH staff, advise, strategically plan, and manage programs to facilitate lead optimization, IND enabling, and clinical studies

c) Serve as a resource to the LDT for toxicology requirements, pharmacology and logistics to conduct biologics development activities for biologics from the preclinical stage through to the initial clinical stage

d) Serve as the toxicology expert in order to identify potential developmental challenges and suggest strategies to address these challenges

e) Collaborate on design of investigative toxicology studies in support of biologics development

f) Review toxicology sections of regulatory filings provided by CROs or PIs

g) Collaborate on the design of investigative studies in support of biologics development.

h) Provide expert support of preclinical strategy development including that for neurological diseases

i) Support in vitro and in vivo model development for neurological disease

j) Support design and interpretation of in silico analyses and in vitro/ ex vivo

screening strategies for oligonucleotides

k) Support of design PK/PD and toxicology safety studies

Performance Area 6 – Medical Writing SME(s)
Medical Writing SME consultants will be responsible for the preparation and submission of high-quality regulatory and other supporting documents for NIH biologics programs. The consultants will coordinate with LDTs to prepare, edit, review, and submit documents to regulatory agencies (e.g., FDA) within project timelines. Documents may include but are not limited to clinical protocols, IND applications, Investigator Brochures (IBs), IND Amendments, Drug Master Files (DMFs), Statement of Investigators (Form FDA 1572), and drug dossiers. The role of the Medical Writing consultant may include but is not limited to the following responsibilities and tasks:

a) Work independently or as part of a team to gather, compile, write, and edit regulatory documents for submission to regulatory agencies

b) Ensure that submissions meet format and content requirements applicable to FDA requirements in compliance with ICH guidelines

c) Manage timelines for regulatory submissions

d) Work independently to complete assigned projects

e) Maintain familiarity with current best industry practices and regulatory requirements that affect medical writing

f) Review and perform quality control (QC) on other documents as part of the overall clinical research process